Cellular and Genetic Mechanisms of Autoimmune Diabetes Associated Neuritis

PROJECT SUMMARY
Type 1 diabetes (T1D) is often accompanied by other autoimmune disorders, including autoimmune
neuropathies. Findings in both NOD mice and patients have revealed potential overlap between immune
responses targeting pancreatic b-cells and nerves. We hypothesized that lymphocyte populations involved in
T1D pathogenesis targeting proteins co-expressed in the nervous system may be the earliest responders
causing initial damage to peripheral nerves. These first responders provide the necessary trigger to expand
immune responses against myelin and other nervous system components traditionally studied in existing
mouse models of autoimmune neuritis. A vast majority of islet-infiltrating B-lymphocytes in NOD mice respond
to the nervous-system protein peripherin. Antibodies against phosphorylated peripherin have been identified in
T1D patients. We recently created a new mouse model (NOD-PerIg) in which B-lymphocytes transgenically
express the immunoglobulin molecule from the peripherin-reactive B-cell clone H280 isolated from islets. T1D
is accelerated in NOD-PerIg mice. T-cells from NOD-PerIg, but not NOD mice, transfer an autoimmune neuritis
similar to chronic demyelinating polyneuropathy (CIDP) to NOD.scid recipients. This new NOD-PerIg à
NOD.scid model of T1D-associated autoimmune neuritis provides an experimental system to directly dissect
the discreet stages of nerve cell infiltration and damage. We originally hypothesized that insulitis expanded T-
cells capable of causing neuritis. However, we have recently determined that T-cells derived from islets or
sciatic nerves in primary NOD.scid recipients are only capable of infiltrating the organ from which they were
derived. Therefore, experiments in Aim 1 will address the current unknowns regarding the discrete temporal
and spatial steps leading to cellular recruitment into peripheral nerves. We have also found that in addition to
the presence of IFNg and TNFa producing CD4+ T-cells, there is paradoxically an expansion of T-cells
negative for traditional Th1, Th2, and Th17 cytokines within sciatic nerves. An additional open question is
whether peripherin remains the antigen towards which T-cells are responding or whether there has been an
expansion of responses against other neuronal antigens. Therefore, studies in Aim 2 will dissect the
mechanisms by which T-cells destroy peripheral nerves and how an immune response against one shared b-
cell/neuronal antigen can spill over to a wider neuronal response. Finally, in large NOD colonies, spontaneous
clinical neuritis can be occasionally observed. We have found that at baseline, NOD mice (around the age of
T1D onset) already have sciatic nerve infiltrating T-cells. These T-cells are not observed in non-autoimmune
prone C57BL/6 mice. This indicates the likelihood that NOD harbors genetic loci contributing to spontaneous
nerve infiltration that can lead to spontaneous neuritis. Whether these loci are distinct or overlapping with loci
contributing to T1D is unknown. Therefore, studies in Aim 3 will map genes associated with spontaneous
nerve infiltration allowing future genetic screening of patients at risk for developing autoimmune neuropathy.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Type 1 diabetes (T1D) is often accompanied by other autoimmune disorders. The goal of this proposal is to gain a clearer understanding of the spatial, temporal, cellular, and genetic contributions to T1D-associated autoimmune neuritis development. Gaining a better understanding of each of these contributory factors will provide a means to potentially pre-screen patients with T1D for a future risk of developing autoimmune nervous system disorders.